Fluorescent Indocarbocyanine PEGylated Lipid Nanoparticles for Understanding and Overcoming Barriers to Drug Delivery in Invasive Glioblastoma

Project Abstract
Glioblastoma (GBM) is the most devastating and aggressive brain tumor in adults, with patients surviving a
median of only 14.6 months. Hidden behind the blood-brain and blood tumor-barrier (BBTB), the glioma cells
migrating away from the tumor and invading surrounding brain tissue, are the source of recurrence. The
invasive cells are not readily accessible to most drug therapeutics, and targeting these cells is an essential
goal for achieving better treatment outcomes. Nanoparticles hold promise for drug delivery, but their
penetration of the BBTB is limited, and the efficiency of targeting invasive cells remains unknown. We recently
discovered that fluorescent indocarbocyanine lipids (ICLs) formulated in PEGylated Lipid Nanoparticles (PLNs)
exhibit highly efficient glioma extravasation, with a single injection resulting in accumulation in ~60% of tumor
cells and up to 30% of injected dose per gram of brain tumor. Furthermore, data in highly invasive models
demonstrate PLNs reach invasive cells at the tumor/brain margin. These findings offer a unique opportunity to
comprehensively understand the mechanism of accumulation of lipid nanoparticles and improve drug delivery
to invasive gliomas. We will pursue the following specific aims: 1) Study the trafficking mechanism of ICLs
across the BBTB and in tumors. In this aim, we will test the hypothesis that lipids migrate in tumors via
extracellular vesicles; 2) Understand the role of lipid structure and formulation in targeting glioma cells
and the tumor immune microenvironment. This aim will test if accumulation in invasive cells and
immunosuppressive cells can be further improved through lipid chemistry, formulation and targeting to glioma
marker IL13R2; 3) Exploit ICLs to understand and improve small molecule delivery to invasive
gliomas. We will explore our previously developed chemistry to conjugate small molecules to ICLs to improve
their delivery, drug release, and therapeutic efficacy of cyclin-dependent kinase inhibitor dinaciclib in invasive
mouse and patient-derived glioma models. These studies will expand our understanding of the drug delivery
process and guide treatment of invasive gliomas with brain tumor-penetrating nanomedicine.

Public health relevance
PROJECT NARRATIVE Glioblastoma (GBM) is the most devastating and aggressive brain tumor in adults, with a median survival of only 14.6 months. The project will use a novel lipid nanoparticle that has the ability to penetrate blood vessels in tumors, in order to deliver drug therapies to aggressive invasive cells in gliomas.